1592U89 W/ STANDARD ZVD THERAPY IN NEONATES BORN TO HIV WOMEN

This study will evaluate the single oral dose pharmacokinetic profile of 1592U89 and will determine the acute toxicity of single dose administration of 1592U89 in HIV-exposed infants.